Homeostatic Regulatory Mechanisms in Nociceptors

ABSTRACT
Mechanical allodynia is a hallmark symptom of chronic pain characterized by painful responses to innocuous
stimuli. However, little is known about the cellular and molecular regulation of this process. Recently, the
mechanically activated Piezo2 channels were identified as key players of mechanical allodynia in mice and
humans, but the molecules and proteins responsible for the sensitization of Piezo2 channels upon injury are
still poorly understood. Recent data from our lab show that activation of Gi-protein coupled receptors induces a
long-lasting potentiation of Piezo2 currents in Dorsal Root Ganglion (DRG) neurons and HEK293 cells. The
potentiation of Piezo2 currents was abolished by inhibiting the activity of Gβγ. Surprisingly, the inhibition of
Gβγ-downstream kinases, phosphoinositide 3-kinase (PI3K) and mitogen-activated protein kinase (MAPK),
also abolished the potentiation of Piezo2 current suggesting an indirect effect of Gβγ on Piezo2 channels.
Therefore, for aim 1 (Ph.D. progress), we described a novel mechanism of regulation of Piezo2 currents by Gi-
protein coupled receptors. On the other hand, our lab has also shown that activation of Transient Receptor
Potential Vanilloids 1 (TRPV1) channels by capsaicin leads to robust inhibition of Piezo2 currents in DRG
neurons and heterologous systems. This inhibition is abolished by removing Ca2+ from the extracellular
solution, confirming a pivotal role of Ca2+ on Piezo2 channels. Preliminary data in our lab using total internal
reflection fluorescence (TIRF) show that Piezo2 channels are internalized upon activation of TRPV1 channels
in HEK293 cells, but whether Piezo2 channels are internalized via endocytosis is not known. For aim 2 (F99
phase), we hypothesize that activation of TRPV1 induces a Ca2+-triggered endocytosis that orchestrate the
inhibition of Piezo2 currents. We aim to identify molecules and proteins that regulate the activity of the
mechanically activated Piezo2 channels. We hope these novel findings could help us understand the process
of tactile allodynia and investigate the changes that affect the periphery and influence the central nervous
systems (aim 3-K00 phase) with the ultimate goal of providing new avenues for treatments of mechanical-pain
syndromes.

Public health relevance
PUBLIC HEALTH RELEVANCE Chronic pain is a leading devastating condition that affects more than 100 million Americans annually with symptoms lasting from week to years. Mechanical allodynia (a process regulated by mechanosensory ion channels) is considered one of the most prevalence hallmarks of chronic pain, but little is known about the processes that contribute to its occurrence. We investigate the molecular and cellular pathways that regulate mechanosensory channels and try to identify the specific molecules and proteins that could potentially become drug targets to mitigate pain conditions.